Laser Scanning Vibrometer

Project Summary
Rigorous biomechanical research relies on quasistatic, dynamic, and viscoelastic characterization. Although this
is well accepted by the research community, experimental constraints, such as a need for minimal manipulation
or a sustained in vivo environment, greatly limit the scope of biomechanical studies. Given the leading role of
the University of California, Irvine (UCI) in biomechanics and mechanobiology, there is a significant need for
innovative biomechanical testing instrumentation that will enable NIH-funded UCI researchers to probe many of
the field’s unanswered questions beyond the capabilities of UCI’s existing equipment. In this proposal, we
demonstrate the need for the purchase of a Polytec PSV-500-3D QTec Laser Scanning Vibrometer to support
numerous NIH-funded research projects. The proposed Vibrometer’s ability to characterize the dynamic and
viscoelastic properties of complex biological samples and biomaterials without damage is unparalleled. This
proposal clearly delineates the major drawbacks of UCI’s current biomechanical testing equipment. In contrast
to these instruments, the proposed Vibrometer’s advantages are extensive and include rapid contactless
measurements, high resolution 3D scanning, multi-scale measurement capabilities, and portability, among
others. These features are critical to maintaining highly demanding experimental conditions in complex studies,
such as longitudinal characterization of cultured tissues or measurements concurrent with operating room
procedures. There are no other instruments on campus or on the market that provide the proposed Vibrometer’s
unique features. This proposal has been prepared by Drs. Kyriacos Athanasiou (PI), Jerry Hu, and Gabriela
Espinosa in consultation with five other Major Users (Drs. Naomi Chesler, Anna Grosberg, Wendy Liu, Joshua
Mauney, Ronke Olabisi) and three Minor Users (Drs. Zhongping Chen, Elliot Hui, Liangzhong Xiang). The initial
set of Users represent numerous areas at the intersection of engineering and medicine, including
mechanobiology, bio-microelectromechanical systems, tissue engineering and biomedical imaging. It is
anticipated that interest in the proposed Vibrometer’s use will only increase, thus expanding its impact on current
and future NIH-funded research at UCI.

Public health relevance
Project Narrative This Shared Instrumentation Grant (SIG) is for the purchase of the Polytec PSV-500-3D QTec Laser Scanning Vibrometer. The proposed Vibrometer will support numerous NIH grants already funded at the University of California, Irvine (UCI), providing fundamental information on functional biomechanical characteristics of multiple biological samples (cell aggregates/clusters, organoids, tissues and organs), as well as biomaterials, in the fields of urology, oral and maxillofacial surgery, ENT, orthopaedics, trauma, dermatology, immunology, and ophthalmology, thus, enabling new therapies to be developed in these areas.